Core D. External Research Resources Support and Dissemination Core

Project Description (Core D): The objective of Core D is two-fold. First, it will provide increased access to new
and novel data sources, through (i) targeted investments in data resources and required computing infrastruc-
ture, (ii) the creation of synergies by expanding the use and research-potential of previous investments in aging-
related data and resources created by PARC’s research networks (Core C) and scholars at PARC affiliated
Centers and Schools, and (iii) strategically cultivate new data resources that will enhance the research potential
of PARC Associates and members of PARC’s Research Networks for path-breaking research. The second ob-
jective of Core D is to greatly expand PARC’s dissemination efforts of research and methodologies to peers,
policy-makers and other stake-holders. Core D will develop and make available to PARC Associates a research
dissemination infrastructure that supports an innovative portfolio of dissemination pathways to reach scholars
across a wide range of disciplines, within and outside of Penn, as well as other stake-holders. This will allow
PARC Associates to move beyond professional circles that are often centered around disciplines, departments
and core conferences, and transform the reach, and the impact of PARC’s research and researchers, furthering
PARC’s aim of continuing to be a leading NIA center for research on the demography and economics of aging.

Public health relevance
Project Narrative/Public Health Relevance (Core D): Interdisciplinary, co-operative research to advance data- driven analysis in the demography and economics of aging requires significant investments in data and data security. The Population Aging Studies Center at the University of Pennsylvania, along with this Core D, provides the platform for dramatically increasing the availability and access to novel data and data linkages at the crucial juncture of the behavioral, social, and health sciences. At the same time, to speed the knowledge-transfer from social science to policy or stakeholders, Core D makes strategic investments in dissemination, expanding the skill sets of our associates as well as leveraging successful dissemination infrastructure to further PARC’s goal of informing effective health policy responses in aging societies, in the U.S. as well as globally.